DP22-001 A Sentinel Network for Evaluation of the Reach, Implementation, Effectiveness, and Costs of Evidence-Based Lifestyle Interventions to Prevent Type 2 Diabetes in U.S. Adults

Project Summary
Despite tremendous advances in diabetes, Type 2 diabetes (T2D) is a leading cause of preventable death and
disability in the U.S., and more than 1.5 million more Americans develop T2D every year. More than half of
those new cases could be prevented or delayed if high risk adults were offered resource-intensive lifestyle
intervention programs while they have prediabetes – a readily identifiable stage of abnormal glucose
metabolism that precedes the development of type 2 diabetes. Currently, 88 million Americans have
prediabetes, but about 5 in 6 of them is unaware, and fewer than 1% have participated in an intensive lifestyle
intervention.
CDC created the National Diabetes Prevention Program (NDPP) to address the increasing burden of type 2
diabetes in the United States. The NDPP lifestyle change program is offered through CDC recognized
organizations, including community-based organizations, hospitals, provider groups, pharmacies, and health
plans in a variety of delivery approaches (in person, online, remote classroom or telehealth). Since 2018, the
Medicare Diabetes Prevention Program (MDPP) has also offered a structured lifestyle intervention program
designed to prevent type 2 diabetes in individuals 65 years and older with prediabetes.
We propose to develop and implement a collaborative research data collection and evaluation plan that
emphasizes the unique, complementary strengths of several organizations with experience supporting the
delivery of National DPP and/or Medicare DPP interventions to reach diverse populations in multiple contexts
and in multiple formats. Our proposal will integrate several sources of data needed to successfully evaluate
participation barriers and facilitators, effectiveness, costs, and cost-effectiveness of efforts to implement
evidence-based diabetes prevention services as part of the NDPP and MDPP. In collaboration with large
health systems and DPP suppliers in several representative “sentinel” locations nationally, we will collect,
manage, harmonize, and analyze multiple data sources, including: (1) health system partner data regarding
participant eligibility characteristics, participation barriers and facilitators, and change in biometric outcomes
over time; (2) NDPP supplier data regarding attendance levels, weight changes, participant experience, and
implementation challenges; and (3) large health payer data for traditional Medicare beneficiaries nationally,
UnitedHealthCare (UHC) commercially ensured health plan enrollees nationally, UHC Medicare Advantage
enrollees nationally, and UHC Medicaid Managed Care enrollees in select states that participate in NDPP.

Public health relevance
Project Narrative Type 2 diabetes (T2D) is a leading cause of preventable death and disability in the U.S., and more than 1.5 million more Americans develop T2D every year. More than half of those new cases could be prevented or delayed if high risk adults were offered resource-intensive lifestyle intervention programs while they have prediabetes. Our proposed center will develop a collaborative network of “sentinel” health systems, National Diabetes Prevention Program and Medicare Diabetes Prevention Program delivery organizations, and experts in natural experimental research using “real world” data. We will collect and harmonize this data and, using rigorous natural experiment designs to identify individual, social, and structural barriers to, and facilitators of, participation in and completion of NDPP and MDPP services and 2) evaluate the long-term effectiveness and cost-effectiveness of structured lifestyle interventions, as implemented under the NDPP and MDPP.